Markers and Mechanisms of PASC

SUMMARY
Inflammatory responses to SARS-CoV-2 infection play a major role in COVID-19 pathogenesis, as the
expression of various inflammatory mediators/regulators correlates with the disease severity and mortality rates.
While the majority of COVID-19 patients fully recover from the infection and become asymptomatic,
approximately one-third of COVID-19 survivors experience a wide spectrum of symptoms and/or complications
beyond 4 weeks from the onset of the disease, now designated as “post-acute sequelae of COVID-19 (PASC)”;
and this syndrome has become increasingly recognized and concerning. While the molecular basis of PASC is
unknown, its clinical healthcare impacts are enormous, raising an urgent need to study long-term outcomes in
our Veteran COVID-19 survivors. The objectives of this proposal are to identify and characterize biomarker(s)
and molecular/cellular mechanisms for the PASC in COVID-19 survivors to better understand and manage this
post-infection syndrome. Our recent investigations into the biochemical and cellular responses to SARS-CoV-2
infection revealed sustained inflammation and immunosuppression in COVID-19 survivors with PASC - also
called COVID-19 long haulers (COV-LH). Specifically, we discovered significant changes in the expression of
multiple inflammatory proteins in COVID-19 survivors, especially in COV-LH, suggesting persistent inflammation
in these subjects. We also found significant increases in myeloid-derived suppressor cells (MDSCs), along with
decreases in the numbers and functions of natural killer (NK) cells in these subjects. Importantly, the increase in
MDSCs was associated with a decrease in NK cells in COV-LH compared with COVID-19 asymptomatic
survivors (COV-AS), indicating sustained immunosuppression in these subjects. Based on our findings, we
designed a research plan to address three critical questions: 1) Can unique signature molecules be identified as
biomarkers for COV-LH? 2) Do these regulatory molecules promote MDSC expansion and suppressive functions
in COV-LH? 3) Are these regulatory molecules and/or is MDSC-mediated immunosuppression responsible for
the development of PASC in COV-LH? Based on our preliminary studies, we hypothesize that SARS-CoV-2
infection induces systemic inflammation and epigenetic and metabolic changes, leading to persistent
inflammation and immunosuppression and the development of PASC in COVID-19 survivors. We propose three
specific aims to test our hypothesis: Aim 1 will identify potential biomarkers and investigate their transcriptional
dysregulations in COVID-19 survivors. Aim 2 will determine the molecular mechanisms that promote MDSC
expansion and suppressive functions in COVID-19 survivors. Aim 3 will determine the role of regulatory
molecules and MDSC-induced immunosuppression in the development of PASC in COVID-19 survivors.
Because there are no known molecular or cellular biomarkers for the diagnosis and treatment of PASC,
information gained from this research will not only fill major knowledge gaps in understanding this post-COVID-
19 syndrome, but will also facilitate identifying and managing PASC symptoms in our Veteran COVID-19
survivors.

Public health relevance
NARRATIVE Recent evidence suggests that systemic inflammation followed by sustained immunosuppression determines the morbidity and mortality as well as the long-term outcomes of SARS-CoV-2 infection. Notably, a significant proportion of COVID-19 patients who survive the acute phase of viral infection develop PASC. The molecular and cellular mechanisms underlying PASC remain largely unknown. Thus, understanding these mechanisms is clinically significant and will have a high impact on COVID-19 research. This proposal will identify signature biomarkers and fundamental mechanisms that could inform the development of new tools for the diagnosis and treatment of the long-term outcome of this devastating disease affecting our Veteran population.